Rare Disease Clinical Research Training Program

Abstract
The goal of the R25 Rare Disease Research (RDR) curriculum is to prepare a multidisciplinary and diverse group
of 50 Scholars per year to perform clinical and translational research in both genetic and non-genetic rare
disorders. This will be accomplished using a one-year 80 hr. blended teaching model. An objective of this
program is to create online modules, pod cast-style lectures, recorded didactic-style lectures and in person
experiences that enable learners from different disciplines and diverse backgrounds to actively participate in this
RDR curriculum. The field of RDR and care delivery recognizes that collaborative research and team science are
critical to improving therapeutic opportunities and wellbeing of the rare disease community. This concept serves
as the unifying theme of the curriculum. Furthermore, in addressing the issue of health equity and systemic
racism there is the need for training RDR leaders and practitioners from populations underrepresented in
medicine (UIM). As part of this objective, we will also prioritize the recruitment of Scholars from these
populations with the goal of having at least 20% of Scholars coming from populations UIM. Recruitment will
include the launching of a more expansive list of disciplines from which we will recruit scholars and creation of
an alumni participation program. We also will highlight how researchers and Scholars will “bring the table to the
participants” in RDR. By changing how the next generation of clinical researchers view recruitment and
engagement in the diverse family and patient rare disease communities, we expect to advance health equity.

Public health relevance
Project Narrative As the number of rare disorders grow each year, the need for new treatments, approaches, and understanding continues to expand. This program has a five-year track record of successfully increasing early career clinical researcher’s intent to remain in research. By continuing the successful program, expanding to a broader group of clinical researchers, and creating an alumni longitudinal component, this program will continue to support the clinical research pipeline.